Roybal Translational Research Center to Promote Context-Specific Caregiving of Community-Dwelling Persons Living with Alzheimer's Disease or Related Disorders

Abstract. This application seeks support for an administrative supplement to the Emory Roybal Center for Dementia Caregiving Mastery (P30AG06400). We seek to develop and test a broadly accessible and readily scalable online fully asynchronous course for family caregivers of community-dwelling persons living with dementing disorders like Alzheimer's disease to prepare them to master the new demands of their caregiving role in the extraordinary circumstance of the coronavirus (COVID-19) pandemic. Under normal circumstances, caregivers need to learn how to guide their person through safe, calm, and pleasant days. In a time of COVID- 19, caregivers have to learn how to take all of the complicated precautions to keep themselves and their persons from being exposed to the virus. They need skills for keeping their persons occupied and calm in a “shelter in place” world where day programs or other regular outings to large group settings (e.g., places of worship) are unavailable. And they need skills for navigating the healthcare system to manage their person's health in ways that minimize the need to use emergency or acute services. We seek to produce an online course that can be completed in 4-6 weeks that will develop and enhance caregivers' mastery not only to provide effective day-to-day care guidance, but to ensure their care recipients' health and safety, and to function as healthcare system navigators for their care recipients. The course will engage caregivers in self- paced learning in a format tailored to and calibrated for a lay learning audience. It will be structured as a small group “class,” of 20-30 participants who will interact virtually but never meet as a group, and whose activities and exercises will be monitored by a course faculty member. In our Aim 1 activities, we propose to develop, in collaboration with an educational design consultant team, the online course designed to teach these skills. The project will seek input from caregivers, clinicians, and other experts ? and used the Roybal Center's Design Studio capacity ? to develop the structure, content, and “feel” of the course and produce a testable prototype. In our Aim 2 activities, we will recruit 100 family caregivers to take part in a quantitative and qualitative wait-list control randomized trial of the prototype course. The trial will assess usability and acceptability and it will be sufficiently powered to examine the preliminary efficacy of the course to develop caregiving mastery and benefit caregivers' well-being. Formative evaluation data, course faculty observation, and course use data will be used to produce a revised version of the course. MPIs Hepburn and Clevenger bring psychoeducation and continuing education program development experience and extensive clinical and caregiver expertise to the project ? and an established working relationship with the educational consulting team. The Aim 2 test will provide the basis for an application for a larger randomized trial through an R01 mechanism. The results of the Aim 2 test will also support making the course more widely available through reliable channels that can provide appropriate course supervision, such as the NIA-supported Alzheimer's Disease Centers.

Public health relevance
Lay Summary: The COVID-19 pandemic adds enormous challenges to the already taxing – and critical – role of family members who provide community-based care to the millions of Americans living with Alzheimer's disease and similar illnesses. This project will develop and test a fully asynchronous online course designed to enhance caregivers' mastery in maintaining the safety and well-being of care recipients and assisting them to navigate the healthcare system during this time of pandemic. The randomized wait-list control trial of the developed prototype course will establish the preliminary efficacy of the course to enhance COVID caregiving mastery and to support caregiver well-being and support revisions that will allow the course to be made available for distribution through reliable channels that can provide appropriate course supervision.